Reprogramming glutamine metabolism in pancreatic beta cells

Project Summary
Progression to type 2 diabetes results from the inability of insulin secreting pancreatic  cells to compensate
for increased insulin demand, usually in the setting of obesity. We have previously found that the
homeodomain transcription factor and human diabetes gene Pdx1 coordinates islet compensation in the
setting of diet-induced obesity and associated insulin resistance. We identified Gpt2 as a target of a PDX1-
ATF transcriptional complex whose stress induction and PDX1 enrichment of regulatory CARE sites is
conserved in both human and murine islets. Importantly, silencing of the transaminase Gpt2 ex vivo protects
primary mouse β cells from stress induced apoptosis. GPT2 is a rapid equilibrium transaminase that catalyzes
a bidirectional reaction converting glutamate and pyruvate to α-ketoglutarate (-KG) and alanine. Recent
reports implicate Gpt2 upregulation as a key step in the reprogramming of glutamine metabolism of cancer
cells. The production of -KG feeds into the tricarboxylic acid (TCA) cycle, resulting in synthesis of ATP which
leads to closure of KATP channels, membrane depolarization, calcium influx and exocytosis. TCA cycle
intermediates also act
enzymes
as a cofactors for several chromatin-modifying enzymes, including the Tet family of
involved in DNA demethylation. Our preliminary findings support the exciting hypothesis that the
induction of GPT2 during fuel excess reprograms beta cell metabolism, thereby causing beta cell dysfunction
and death. This hypothesis and the underlying mechanisms will be tested in the following Aims: Aim 1: To
uncover the mechanism whereby the transaminase Gpt2 promotes  cell dysfunction and death. We
will (A) complete the in vivo characterization of Gpt2 deficiency in pancreatic  cells, (B) elucidate how Gpt2
deficiency affects mitochondrial morphology, function and metabolism, (C) explore the epigenetic impact of
Gpt2 silencing and (D) assess the role of Gpt2 in human  cell function and survival during metabolic stress.
Aim 2: To elucidate how Gpt2 influences sensitivity of the  cell to GLP1. We will (A) determine whether
the sensitivity of GIP and other insulin secretagogues are also affected by Gpt2 expression, (B) investigate the
molecular mechanism whereby GPT2 impacts GLP1 sensitivity, and (C) determine whether its impact on cell
survival and function is linked to its effect on GLP1 sensitivity via intraislet paracrine signaling. These results
will address an important gap in our understanding of how glucoliptoxicity promotes  cell dysfunction and
death. Further we will then be poised to devise strategies to target Gpt2 activity or expression as a therapeutic
means to protect beta cells during metabolic stress and to enhance sensitivity to Glp1 receptor agonists, an
application of the proposed studies that is of the highest translational relevance.

Public health relevance
Project Narrative Progression to type 2 diabetes results from the inability of insulin secreting pancreatic  cells to compensate for increased insulin demand, usually in the setting of obesity. Here we investigate the role of a regulatory enzyme that influences mitochondrial metabolism and whose silencing protects  cells from dysfunction and death during metabolic stress. Results of the proposed studies will address an important gap in our understanding of how glucoliptoxicity promotes  cell dysfunction and death and will position us to devise new therapeutic strategies to protect beta cells during metabolic stress.